Novel mouse models to dissect the role of genetics, sex, and environment in heterogeneous outcomes in CNS autoimmune disease

PROJECT ABSTRACT/SUMMARY
Multiple sclerosis (MS) is a chronic disease that is the leading cause of non-traumatic neurological disability in
young adults. The disease is caused by an aberrant immune-mediated attack on the central nervous system,
which causes tissue destruction and subsequent neurologic disability. Disease course varies greatly from
individual to individual, from relapsing-remitting MS, to primary progressive MS, the latter highly debilitating and
refractory to treatment. MS is three times more common in women, but tends to be more severe in men. MS has
a significant heritable component, with up to 30% of the disease risk being genetically determined. While recent
studies have identified candidate genes that are associated with MS risk, it remains unclear how these genes
work and whether these are truly causative. Additionally, it is completely unknown why some individuals get
different forms of this disease, and why there are differences between men and women. The other 70% of
disease risk comes from environment or gene-by-environment interactions, representing an attractive avenue
for presentation. However, how risk factors, in particular chronic gammaherpes virus infection, mechanistically
impact MS risk or progression is unclear. These types of questions are very difficult, if not impossible, to address
in studies in humans, and in this application, we propose to use animal models of MS. Mouse models offer
powerful genetic tools, and allow for cause/effect mechanistic studies, but conventional mouse models are highly
artificial and lack genetic diversity. We will use several novel mouse genetic models that are designed to better
represent the complex genetic structure of human populations, which will allow us to dissect the complex genetic
architecture underlying MS pathogenesis, to identify specific genes responsible for various poorly understood
aspects of this disease, and to identify gene-by-environment interactions and novel mechanisms underlying
environmental risk factors.

Public health relevance
PROJECT NARRATIVE Multiple sclerosis is a polygenic and multifactorial chronic autoimmune disease that is the leading cause of non- traumatic neurological disability in young adults. The genetic and environmental molecular mechanisms underlying many aspects of this disease are not well understood. In this application, we propose to utilize several novel systems genetics approaches in mice to identify pathogenetic and environmental mechanisms underlying progression of this disease.